Understanding and leveraging molecular diversity within the phytochrome superfamily

Understanding and leveraging molecular diversity within the phytochrome superfamily.
Our proposal focuses on the phytochrome superfamily of photoreceptors. We have a longstanding
interest in these proteins and in the linear tetrapyrrole (bilin) chromophores they use to detect
light. Members of this superfamily control growth and development of plants (seed germination,
photomorphogenesis, shade avoidance, and flowering, among other processes), making
phytochromes important research targets for enhancing agricultural efficiency to meet the
demand for food in the face of increasing human population. Other members of this family allow
bacteria to move, form biofilms, or adjust their metabolism in response to the light environment.
Phytochromes and cyanobacteriochromes (CBCRs), the two families of proteins in the
phytochrome superfamily, are able to detect every color of light between the near-ultraviolet and
the near-infrared, including red and far-red wavelengths that are optimal for imaging in
mammalian tissue. Thus, basic research to understand phytochrome diversity, the mechanisms
underlying its function in plants, algae, and bacteria, and development of new imaging tools well
fits the mission of NIGMS.
Research in the Lagarias lab leverages the natural diversity that has arisen in this
superfamily during evolution. We seek to understand the mechanisms that allow these proteins
to sense different colors of light, to either exhibit bright fluorescence or switch between
photostates, to integrate signals such as temperature or pH with light, and to report this
information to the cell. In the course of this research, we have also developed useful reagents
including fluorescent phytochromes, constitutively active plant phytochromes, and phytochrome-
null plants. In the next five years, we envision making further progress in understanding detection
of far-red and near-infrared light by these proteins. We expect to learn how to “re-tune” the color-
sensing mechanisms of a range of phytochromes and CBCRs, an insight which be applied to
existing reagents and systems to allow new imaging applications, multiplexing of synthetic biology
systems to respond to different colors, or tissue-specific applications in which specific targets are
activated with light rather than with gene promoters. These goals fit well with our overall goals of
understanding of the photochemical, biophysical, and biological processes of this family and
potentially yield advances in biomedical imaging and synthetic biology via development of a
knowledge base, improving fundamental methods with new reagents, and leveraging new
technologies.

Public health relevance
This project examines the phytochromes, a superfamily of photoreceptors that can detect to a broad range of colors and can transmit that information to the cell to control many aspects of biology. Plant phytochromes are a major stumbling block in improving agricultural yield by mediating the shade avoidance response caused by competition for light among neighboring plants, while their bacterial relatives have proven a valuable source of imaging reagents for biomedical research and of photosensory reagents for synthetic control of cellular processes with light. Work under this project will provide new insight into color tuning, the usage of light energy, the integration of light with signals such as temperature and pH, and the transmission of information within these photoreceptors and to the rest of the cell.